Administrative Core

PROJECT SUMMARY
ADMINISTRATIVE CORE
The Developmental Exposure Alcohol Research Center (DEARC) supports projects and investigators at
Binghamton University to advance rigorous studies to understand ethanol action(s) on the developing brain so
that effective treatments (cognitive, behavioral, pharmacotherapeutic, etc) can be developed and optimized for
the future. The proposed renewal of the Center includes 5 Main Projects and a Pilot Project Core. The
Administrative Core provides the organizational framework for the efficient management, direction, and
coordination of Center activities to ensure that Center-wide goals and objectives, as described in the Overall
Component, are fully realized. In essence, the policies, procedures, and Aims outlined in the Administrative Core
become the tools through which the vision of the Overall Component is achieved. Led by the Center Director
and the Scientific Director, the Administrative Core provides scientific leadership, identifies opportunities for
collaboration, and promotes synergistic outcomes through strategic planning and guidance of all scientific
components. The Administrative Core ensures scientific components have the scientific, technical, and financial
resources to be successful, including access to software, equipment, protocols, and other readily share-able
materials. Structured oversight provided through regular review of scientific progress, standardization of
technical approaches, and protocol sharing accelerate progress, strengthen scientific rigor, and enhance
reproducibility of scientific findings. The Administrative Core is uniquely poised to broaden the scientific impact
of discoveries arising from Center-supported projects through strategic communications, presentations, and
coordination with external agencies including but not limited to, the Research Society on Alcohol, ISBRA/ESBRA,
and program staff at NIAAA. The Administrative Core supports the professional development of investigators at
all career levels, with a specific priority of engaging and training scholars from diverse backgrounds. The goals
of the Administrative Core, therefore, are to facilitate interaction and promote the highest quality research among
projects by providing clear leadership, efficient management, strong administrative, fiscal and research
infrastructure, and by advancing the integration of projects as a means to achieve synergistic outcomes from the
Center as a whole.